FLAVIN-CONTAINING MONO-OXYGENASES AS NOVEL INNATE IMMUNITY EFFECTORS

F"avin-containing monooxygenases (FMOs) are conserved intrace""u"ar enzymes that oxidize organic mo"e-
cu"es, such as xenobiotics, and promote their export by p"asma membrane transporters. We recent"y discov-
ered that FMOs are important innate host defense effectors. This project uses an in vivo reductionist approach
with Caenorhabditis e5egans as mode5 organism to improve understanding of the host defense functions of
FMOs. The "ong-term goa" of this project is to understand how C. e5egans and mamma"ian FMOs are regu-
"ated and how they promote host defense during infection. Our prior research supports the idea that C. e5e-
gans FMO-D, human FMOE, and other FMOs may possess evo"utionari"y conserved functions in host-microbe
interactions. What these functions are and how they are regu5ated is current5y unknown. This is an important
fundamenta" know"edge gap that impedes understanding of homeostasis and host defense in anima"s, and
that obscures therapeutic opportunities to treat infections or inf"ammatory diseases. The overa"" objective of
this deve"opmenta" app"ication is to increase mechanistic understanding of FMO-D/FMOE function in the con-
text of host defense against bacteria" infection and to deve"op nove" approaches and mode" organisms, thus
enab"ing future studies to e"ucidate the ro"es and regu"ation of FMOs in C. e5egans and mamma"ian innate im-
munity. This project’s centra" hypothesis is that HLH-CD/TFEB and NHR-JK/PPAR-α induce expression of
FMO-P/FMOQ for host defense via FMO-P activity-dependent antimicrobia5 mechanisms. To test this hypothe-
sis, we wi"" Define upstream mechanisms of fmo-P/FMOQ gene regu"ation and downstream mechanisms of
FMO-D/FMOE-mediated host defense. The proposed research is technica""y innovative because of innovations
in the app"ication of new methods to determine peroxidized "ipids in C. e5egans, for the use of synthetic "etha"-
ity to uncover specific and genetica""y redundant tissues of action, and for use of genetic comp"ementation for
in vivo functiona" eva"uation of reconstructed ancient mamma"ian FMOs in C. e5egans. Additiona""y, the pro-
posed work is conceptua""y innovative for connecting HLH-MN/TFEB to NHR-ST/PPAR-α for the regu"ation of
FMO-D/FMOE (revea"ing a nove" connection between metabo"ism and innate immunity) and for its proposed
ro"e for FMO-D/FMOE as source of ROS and oxidized signa"ing "ipids during infection. This proposa" is high"y
re"evant to human hea"th because it focuses on genes and pathways that are conserved in humans. This pro-
posa" is high"y significant because it direct"y addresses the important gap in fundamenta" know"edge of FMO
ro"es and regu"ation as innate immunity effectors. Moreover, the reagents, assays, new mode" organisms, and
know"edge gained through this deve"opmenta" project wi"" open new avenues of research into innate immunity
and FMO function and he"p create a path forward for the rationa" design of host-directed therapeutics against
bacteria" infections and microbiota dysbiosis. Therefore, this proposa" is high"y re"evant to human hea"th, and
we expect this project to have an important and broad positive impact.

Public health relevance
The proposed research is high.y re.evant to pub.ic hea.th because it wi.. great.y advance mechanistic understanding of how FMOs promote host defense against infection in vivo. Moreover, the reagents, assays, new mode. organisms, and know.edge gained through this deve.opmenta. project wi.. open new avenues of research into innate immunity and FMO function and he.p create a path forward for the rationa. design of host- directed therapeutics against bacteria. infections and microbiota dysbiosis. The proposed research is re.evant to the part of the NAH’s mission that pertains to deve.oping fundamenta. know.edge that wi.. he.p to reduce the burden of human disease.